Optimization, Pharmacokinetics, and Efficacy of an IgG Protease for the Treatment of Immune Thrombocytopenia and Other IgG-Mediated Autoimmune Diseases

ABSTRACT
Immune thrombocytopenia (ITP) is an autoimmune disorder caused by antiplatelet IgG autoantibodies that cause
a marked reduction in platelet counts, increasing the risk of severe bleeding and bruising, and lowering patient
quality of life. Current treatments, including corticosteroids and intravenous immunoglobulin, have partial efficacy
and side effects. Efgartigimod alfa, an antagonist of the neonatal Fc receptor that lowers circulating IgG levels,
has demonstrated limited efficacy that supports reduction of IgG as an effective therapeutic mechanism but also
underscores the need for enhanced depth of IgG depletion. We are developing the bacterial IgG protease IdeS
(Immunoglobulin Degrading Enzyme from Streptococcus pyogenes), engineered for reduced immunogenicity
and an extended in vivo half-life, to treat ITP by the rapid and durable depletion of antiplatelet autoantibodies.
Engineering of the IdeS sequence leverages computational AI protein design tools with extensive experimental
validation to identify and remove T cell epitopes that are displayed on HLA class II (HLA-II). By incorporating
glycosylation sites and fusing IdeS with human serum albumin (HSA), surface epitopes exposed to B cells are
shielded and the enzyme's half-life is extended. As a result, we have created short-acting (CYR241) and long-
acting (CYR212) drug development candidates for assessment in a chronic ITP mouse model. Additionally, we
have computationally designed de novo albumin-binding domains (ABD) with potential for low immunogenicity
and intermediate pharmacokinetics (PK), allowing for control over the therapeutic duration of IgG depletion and
minimizing infection risks associated with hypogammaglobulinemia. (Aim 1.1) In this proposal, we will
experimentally evaluate the immunogenic risk of the ABD sequence by displaying ABD-derived peptides on yeast
and measuring binding to common HLA-II alleles following a HLA-DM catalyzed antigen loading reaction. (Aim
1.2) As necessary, we will remove potential immunogenic epitopes by mutagenesis and finalize an IdeS-ABD
fusion protein sequence. (Aim 2) We will evaluate the PK of the short (CYR241), putative medium (IdeS-ABD),
and long-acting (CYR212) IdeS proteins in a double-humanized hSA/hFcRN mouse model to provide human-
like PK. (Aim 3) Utilizing a non-lethal chronic ITP mouse model, we will assess the therapeutic efficacy of
CYR241, CYR212, and our final IdeS-ABD candidate. The model, driven by continuous passive transfer of
polyclonal rabbit anti-mouse thrombocyte antibodies that mimics sustained autoantibody synthesis, will allow for
evaluation of the IdeS variants' ability to mitigate disease through sustained platelet count improvement and
antibody degradation activity over time. By the program's completion, we expect to have a set of three
development candidates with different durations of action that are ready for IND-enabling studies. Clinical
considerations will eventually inform which candidate/s proceed, balancing efficacy and safety. This innovation
not only addresses a clinical need for improved ITP management but also opens possibilities for treating a range
of IgG-mediated autoimmune diseases.

Public health relevance
NARRATIVE Immune thrombocytopenia (ITP) is an IgG-mediated autoimmune disease characterized by dangerously low platelet counts and bleeding. A bacterial IgG protease has been engineered with reduced immunogenicity and extended half-life for the rapid and durable reduction of IgG autoantibodies that are responsible for ITP. We will optimize an IdeS variant with albumin-binding features to provide a set of three IgG proteases with half-lives ranging from hours to days and demonstrate their efficacy at restoring platelet counts in a mouse model of the disease.